Improved risk scoring and patient attribution methods for medical home evaluation.

? DESCRIPTION (provided by applicant): The specific goal of this proposed work is to develop optimal risk scoring and patient-clinic attribution methods for medical home applications. This proposal outlines methods intended to provide the accuracy and completeness needed to accomplish those goals. These efforts are directly linked to care provision models intended to improve population health and healthcare delivery processes.

Public health relevance
PUBLIC HEALTH RELEVANCE: Payment methods and performance measurement are central to implementing health reform changes such as medical homes and accountable care organizations. Two central methodological issues related to payment are risk adjustment for Medicaid and Medicare populations for payment and attributing patients to clinics for performance measurement. Two related difficulties in implementing health reform are (a) constructing risk adjustment scores that are not unduly biased by unstable or incomplete encounter and insurance enrollment patterns and (b) reliably attributing patients to clinics to support clinic level measurement of cost and quality. These two issues are related since both attribution processes and risk scoring derive from primary medical claim sets. We propose to examine the impacts of enrollment stability and duration on both of these issues using populations of Medicare and Medicaid patients.